Dissecting motor cortex modulation of nociception during chronic pain

PROJECT SUMMARY (See instructions):
The heavy burden of chronic pain and the opioid epidemic has prompted an urgent, worldwide search for
alternative, non-addictive methods of analgesia. One promising alternative is non-invasive electrical or
magnetic stimulation of the motor cortex (MC). While MC stimulation (MCS) has repeatedly been found to
reduce chronic pain in human subjects and decrease nociceptive behaviors in rodent models, major
questions remain about its mechanism of action and how to improve MCS efficacy. Evidence suggests
that MCS antinociceptive efficacy increases when the stimulation targets the region in motor cortex that
corresponds to the body part from which pain originates (somatotopically matching MCS) and that MCS
analgesia requires endogenous opioid activity. Here, I propose to use a rodent model of trigeminal
neuropathic pain to elucidate the underlying mechanism of MCS antinociception and to define key MCS
features that pain clinicians can use to improve MCS efficacy. To characterize the MCS mechanism, I will
1) quantify the efficacy of somatotopically matched MCS (ssMCS), 2) determine what opioid receptor
subtypes are required for MCS antinociception, and 3) identify how endogenous opioids modulate an
opioid-sensitive MC descending circuit to the descending pain control pathways during ssMCS.
To determine the efficacy of MCS between matched and off-target MCS in two different nerve constriction
models, I will use classic behavioral paradigms along with cutting-edge machine learning algorithms to
analyze mouse behavioral responses. I will then use complementary pharmacological and genetic mouse
lines to determine how ssMCS is impacted by distinct opioid receptor types. To interrogate the combined
impact of MC somatotopy and endogenous opioid signaling in MCS analgesia, I will focus on the
descending projection from MC to descending pain control regions, rostral ventromedial medulla (RVM)
and spinal trigeminal nucleus caudalis (SpVC). I will determine the positions of opioid receptor types and
endogenous opioid peptides along this circuit and then assess the impact of ssMCS with and without
opioid signaling on neural activity in MC, RVM, and SpVC using cutting-edge high-density
electrophysiological techniques. Altogether, this project will determine how MCS modulates nociception
through endogenous opioid signaling in somatotopically aligned circuits. The results will provide the first
report of neural activity during and after ssMCS at both the target and in an MC output.

Public health relevance
RELEVANCE (See instructions): More than 100 million Americans suffer from chronic pain today, some of whom become addicted to opioid methods of pain relief. Noninvasive stimulation of motor cortex has been found to be an effective opioid-alternative method of pain relief, but no one knows how it works. This research project proposes to investigate how targeting the stimulation within motor cortex elicits activity of the body's natural pain signaling pathways.